Somatic instability of CAG repeats in spinal and bulbar muscular atrophy

Many neurodegenerative diseases, including Huntington’s disease, ALS, several adult-onset spinocerebellar
ataxias, and spinal and bulbar muscular atrophy (SBMA) result from the inherited expansion of a repeated
nucleotide sequence. Spinal and bulbar muscular atrophy (SBMA) is an adult- onset, inherited neuromuscular
disease that is caused by polyglutamine-encoding CAG nucleotide repeat expansion within the androgen
receptor (AR) gene; it is related to other neurodegenerative diseases caused by polyglutamine-encoding
CAG expansion, including Huntington’s disease and several spinocerebellar ataxias. Although the precise
pathway leading to neuronal dysfunction and death is unknown, the evaluation of transgenic mouse and cell
models of these diseases has yielded mechanistic insights to disease pathogenesis. SBMA stands apart
from other polyglutamine diseases in that its onset and progression are dependent on AR androgenic ligands;
therefore, SBMA exclusively affects men. Many cell and mouse models of SBMA reproduce the androgen-
and polyglutamine- dependent nuclear AR aggregation seen in patients, as well as its consequent toxicity,
making these models highly useful for the analysis of the mechanistic basis for upstream events involved in
AR toxicity. Our long-term objectives are to use these models to develop a mechanistic understanding of
SBMA pathogenesis and to develop therapeutic approaches based on that understanding. Recent studies
have revealed that SBMA symptoms do not result exclusively from the dysfunction and ultimate death of
spinal motor neurons. Rather, SBMA results from deficits in the neuromuscular system, with both myogenic
and neurogenic pathology observed in affected muscles. Recent advances in the role of somatic CAG repeat
instability in Huntington’s disease and mechanistic insights into the role for mismatch repair pathway in
somatic instability prompted our re-evaluation of somatic instability in SBMA. Our preliminary data reveal
somatic expansions in muscles but not in spinal cord of a knock-in mouse model of SBMA and in autopsy
material from human SBMA patients. Moreover, AR CAG expansions in mouse muscles increase with age.
We propose in this application to evaluate the tissue selectivity and temporal relationship of somatic
instability in aging SBMA mice and in human SBMA muscle biopsies and to investigate the role of somatic
expansion in the disease process. The outcomes from these studies are likely to reveal a novel mechanism
contributing to SBMA and to identify new therapeutic directions.

Public health relevance
Spinal and bulbar muscular atrophy (SBMA) is one of 9 polyglutamine diseases that are part of a larger family of neurodegenerative diseases characterized by protein misfolding and accumulation; these diseases include Alzheimer’s disease, Huntington’s disease, Parkinson’s disease and amyotrophic lateral sclerosis (ALS). There is an emerging understanding, particularly for Huntington’s disease, that further expansion of the inherited CAG repeat in affected patient tissues may contribute to the onset and progression of disease symptoms. We propose here to understand whether such somatic instability of the CAG repeat contributes to disease in SBMA.